MODIFICATION TO REMOVE OPTION YEAR 1 - OTSS - UNIFIED NCATS AUTH (UNA) MANAGED SERVICE

The National Institutes of Health (NIH) is the Nation’s leading medical research agency and the primary federal agency whose mission is to seek fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance health, lengthen life, and reduce illness and disability by supporting and making medical discoveries. NCATS is the only center at the NIH that focuses exclusively on all aspects of the translation of research with an innovative pipeline of treatment discoveries for all diseases. NCATS brings together a diverse group of scientists, including medicinal chemists, biologists, toxicologists, clinicians, and engineers to translate basic science conducted elsewhere into products and services that help improve people’s health and lives. NCATS’ mission is to improve health through smarter science that results in better treatments faster for all diseases, rare or common.

To serve this wide range of collaborations, the Unified NCATS Auth (UNA) service is critical for federate authentication/authorization services for data contributors across over 80 institutes and medical centers throughout the United States and federated data access for over 1000 institutions worldwide. In order to continue to provide these services and further refine services the UNA team needs support for the operations and continuous development of UNA.